Neurocomputational mechanisms and connectivity dynamics underlying obsessive-compulsive disorder and phenotypical differentiations

Project Summary/Abstract
Obsessive-Compulsive Disorder (OCD) is a psychiatric disorder with a lifetime prevalence of 2-3% in the
general population. It manifests in a variety of intrusive thoughts (obsessions), rigid decision-making and
ritualistic behaviors (compulsions), with prolonged and disabling effects. However, the neural and
computational mechanisms underlying the disorder or its differentiations remain unclear, so that misdiagnosis
is frequent, and even when an appropriate treatment is established, about half the patients keep exhibiting
disabling residual symptoms. In this project, we propose to use an innovative approach, relying on
neurocomputational and connectivity analyses of fMRI data, jointly with multi-model-based computational
analyses of choice behavior across decision-making tasks. With these analyses, the project aims to
characterize OCD symptom severity and phenotype differentiation based on cortico-striatal and cortico-cortical
circuit dynamics, and to establish a relation between network-based phenotypes and model-based
parametrization of choice behavior across decision-making tasks. We will test the predictions of a newly
published neurocomputational theory, and its leading hypothesis that rigidity in motor, planning and goal
selections is caused by aberrant stability of transient dynamics in the dorsal, lateral and ventral cortico-striatal
circuit, respectively. We will test this hypothesis in a population of 140 subjects, equally distributed across five
categories defined on the YBOCS scale of OCD severity (subclinical, mild, moderate, severe and extreme).
We will use Dynamic Causal Modeling and Dependency Network Analysis to estimate subject-specific cortico-
striatal circuit dynamics (with planned redundancy to test convergence of results), and we will use
computational models based on reinforcement learning and Bayesian inference algorithms for the analysis of
choice behavior across decision-making tasks. OCD phenotypes are expected to show task-related motor,
planning and goal selection rigidity, expressed both in terms of model-based parameters of choice behavior
and effective connectivity and network measures responsible for aberrant circuit stability. If validated, this novel
characterization of neurocomputational OCD phenotypes would provide a more comprehensive explanation of
the heterogeneity in OCD symptomatology and treatment responses, helping the development of subject-
specific treatment tools, such as, for instance, personalized neuromodulation targets in deep brain stimulation
or transcranial magnetic stimulation.

Public health relevance
Project Narrative Obsessive-compulsive disorder (OCD) is common, chronic and often difficult to treat disorder that results in prolonged and disabling effects in an estimated 2-3% of the general population, during their lifetime. It manifests in a variety of compulsions and obsessions but the neural mechanisms underlying the disorder or its differentiations remain unclear. In this project, we leverage model-based analysis of behavior and fMRI activity, jointly with brain network analysis, with the aim to provide a more comprehensive understanding of brain dynamics underlying OCD symptom severity and phenotypization.